Contributions of gonadal hormones vs. sex chromosomes in shaping sex differences in epilepsy

PROJECT SUMMARY
Sex differences are present in many forms of epilepsy, both in humans and in preclinical animal models. The
origins of these sex differences remain poorly understood. Although gonadal hormones strongly influence
neural excitability and seizure activity in both males and females, the contributions of sex chromosomes, the
other component of biological sex, in driving differences in seizures between and within sexes are largely
unknown. The studies in this project will apply a unique mouse model, in which gonadal and chromosomal sex
effects can be dissociated, to the study of seizures and epilepsy for the first time. Using a combination of in
vivo video-electroencephalography, RNA sequencing, and immunostaining, we will determine the contributions
of sex chromosomes and gonadal hormones in shaping acute seizure susceptibility and seizure-induced
neuropathology (Aim 1) and spontaneous recurrent seizures and hippocampal gene expression in a mouse
model of chronic temporal lobe epilepsy (Aim 2). This work will have positive translational impact by
addressing the 2021 NINDS Epilepsy Research Benchmark to “identify and understand mechanisms of sex
modulation of epilepsy risk,” and will provide a basis for future mechanistic investigations of the interactions
between sex chromosomes and specific gonadal hormones in shaping neural excitability, seizures, and
epilepsy in both males and females.

Public health relevance
PROJECT NARRATIVE Sex differences in seizures and epilepsy have been found in both humans and animal models. Biological sex comprises both genetic and gonadal sex, but the specific effects and roles of these components can be hard to separate. This project will apply a unique mouse model that enables separation of effects of sex chromosomes from those of gonadal hormones to understand how each component influences seizure activity and gene expression in epilepsy.